Deep South Occupational Safety and Health Education and Research Center

Program Director/Principal Investigator (Last, First, Middle): Lungu, Claudiu T.
Project Summary
The Deep South Center for Occupational Health and Safety (DSC) is a consortium of two major universities in
Alabama, University of Alabama at Birmingham (UAB) and Auburn University (AU) established in 1982 as an
Education and Research Center (ERC) funded by the National Institute for Occupational Safety and Health
(NIOSH). The mission of the DSC is to Train and develop professionals who protect and promote the
health and safety of workers through interdisciplinary education, training, research and outreach.
The DSC offers high quality interdisciplinary graduate training in three OSH academic programs: Industrial
Hygiene (UAB), Occupational Health Nursing (UAB), Occupational Safety and Ergonomics (AU) and one allied
discipline, Occupational Injury Prevention (AU). The DSC has a long tradition of training OSH professionals in
our region through the Continuing Education program and has provided training resources, information and
consulting to businesses and organizations through the Outreach program. The Center is also providing
research training to investigators and students through the Pilot Project Research Training program.
Recognizing the OSH burden that affects disproportionally racial and ethnic minority groups as well as
disadvantaged communities and individuals, the DSC will focus on minimizing this burden while striving to
eliminate disparities showing our commitment to DEI.
The mission of the DSC will be achieved through the following specific aims:
Specific Aim 1: Maintain and enhance our excellence in interdisciplinary academic education. The DSC
will continue to offer high quality academic programs at the level of master’s, doctoral and certification in
Industrial Hygiene (IH), Occupational Health Nursing (OHN) and Occupational Safety and Ergonomics (OSE)
with the allied Occupational Injury Prevention Research Training (OIP) program.
Specific Aim 2: Continue to be the main training and outreach resource of OSH for business and
organizations in the region. The DSC will continue to offer our Continuing Education (CE) core courses to a
broad spectrum of OSH professionals including offering to military personnel on US military bases and health
care professionals (HCPs).
Specific Aim 3: Collaborate with other academic and research institutions, businesses, non-profit and
professional organizations, other ERCs and TPGs to find the best mechanisms and tools to protect the
life, health and wellbeing of broad categories of workers. The DSC will continue to be an active participant
and support state and regional organizations and conferences.
Specific Aim 4: Conduct high quality fundamental and applied research related to the NIOSH NORA
agenda to advance the field of OSH. One of the main goals of the DSC faculty is to develop new knowledge
investigating the causes of occupational diseases and injuries, and proposing new solutions for prevention.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Lungu, Claudiu T. Narrative: The Deep South Center for Occupational Health and Safety (DSC) was established in 1982 as an Education and Research Center with the participation of two major Universities, University of Alabama at Birmingham (UAB) and Auburn University (AU). The mission of the DSC is to Train and develop professionals who protect and promote the health and safety of workers through interdisciplinary education, training, research and outreach. Recognizing the OSH burden that affects disproportionally racial and ethnic minority groups as well as disadvantaged communities and individuals, the DSC will focus on minimizing this burden while striving to eliminate disparities showing our commitment to DEI. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page